Delaware Clinical and Translational Research ACCEL Program (TEVAL Core)

ABSTRACT - Tracking & Evaluation (TEVAL)
The Tracking and Evaluation (TEVAL) Core of the Delaware ACCEL CTR Program (ACCEL-CTR) will facilitate and assess the success of building a sustainable clinical and translational research infrastructure in Delaware. During ACCEL3, the priorities of TEVAL will move beyond defining metrics and accounting for research productivity, which has been a high priority over the past nine years, and transition to a greater focus on summative evaluation, reflective of the maturity of the ACCEL-CTR. The Specific Aims of TEVAL are 1) Monitor and track metrics and key performance indicators of success; 2) Provide evaluation support to CTR and Core leaders to facilitate continuous improvement; 3) Assess the impact of the ACCEL- CTR utilizing multi-level impact studies, focusing on the individual, institutional, infrastructure, and community health levels; and 4) Share best practices in evaluation and clinical and translational research within and beyond Delaware. We will provide CTR and Core leaders with the information necessary to support data-driven decision-making and to facilitate continuous improvement. TEVAL will examine how the ACCEL-CTR has impacted research capacity, infrastructure, collaborations, investments in research addressing the health needs of Delawareans, as well as the translational impact of funded projects in accordance with overall project aims. We will share best practices and lessons learned through evaluation briefs, presentations, infographics, and publications. In addition, the Delaware TEVAL Core leads the National CTR Evaluator’s Network and together with other CTR evaluators will share best practices in translational research evaluation. The work of TEVAL will be guided by the American Evaluation Association’s Guiding Principles for Evaluators: systematic inquiry, competence, integrity, respect for people and common good. ACCEL evaluation will incorporate multiple approaches into its participatory, theory-based evaluation, including a concentration on the intended use of data by intended users (utilization-focused evaluation) and iterative, flexible methods to address innovation and system complexity (developmental evaluation). In addition, our initial planning during which indicators were built into the program’s theory (embedded evaluation) and our intentional focus on intermediate and long-term results towards meeting ACCEL-CTR aims (results-based accountability) are intended to provide stakeholders with the necessary information for summative decision-making. These methods enable TEVAL to provide high quality, actionable analyses and reporting to leaders on outcomes and impacts regarding enhancing infrastructure, strengthening research, fostering collaborations, and improving health for all in Delaware.

Public health relevance
Project Narrative While Delaware has high quality healthcare compared to other states, it still lags behind other states in a number of areas, including drug-related deaths, obesity, high preventable hospitalization rates, multiple chronic conditions and cancer. As such, the overarching goal for the continuation of the ACCEL CTR Program is to create a unified Delaware Clinical and Translational Research Community (inclusive of investigators and community members) that breaks down existing barriers, capitalizes on the unique strengths of its partners to establish infrastructure and accelerates the creation of solutions that improve the health of all Delawareans and all Americans.